Accelerator Strategies for States to Improve System Transformations Affecting Children, Youth and Families

OVERALL: Project Summary/Abstract
The ASSIST Center—Accelerator Strategies for States to Improve System Transformations Affecting Children,
Youth and Families—builds on an infrastructure developed through a 15-year collaboration between New York
University School of Medicine (The IDEAS Center) and the New York State Office of Mental Health, creating
the only national children's policy dissemination and implementation (D&I) research laboratory in the country
focused on improving the uptake of policy-relevant, evidence-based services for youth with serious mental
health disorders (SMHD). ASSIST will develop tools to improve the uptake of child mental health (MH)
research evidence by state policymakers, and test two practical accelerator strategies to improve D&I of
evidence-based practices in state systems. Guided by Shortell's Levels of Change Framework and Leeman et
al's “beyond implementation strategies,” ASSIST's objectives and specific aims support the National Institute of
Mental Health's (NIMH) Strategic Research Objectives 3.3 and 4.4. The specific aims of the Center are to: Aim
1. Advance policy-relevant effectiveness, dissemination, and implementation research across multiple levels of
state systems (policymakers, agencies, providers, youth/families), including meaningful engagement of diverse
Center stakeholders, to improve publicly-funded services for youth with SMHD and their families; Aim 2.
Identify state policy dissemination targets and test a set of brief and practical accelerator strategies (diagnostic
and engagement) to improve clinical practice and youth and family outcomes; Aim 3. Advance the
development of early and mid-career investigators interested in state MH policy and services research through
the Training Unit's comprehensive training opportunities, structured mentoring program, pilot research funding,
and access to a rich set of state and national-level datasets and methodological support (via the Methods Core
[MC]) to support their career development; Aim 4. Identify and develop rigorous, practical, and novel methods
for state policy research for use by health plans, payors, and states via the MC's Project Design and Analysis
Services Unit (PDASU) and Data Coordinating Unit (DCU); and Aim 5. Engage Center stakeholders and
disseminate Center findings nationally, via the Communications and Stakeholder Engagement Unit (CSEU),
which will focus on the engagement and integration of stakeholder input into research projects, and the
national dissemination of Center-developed research products, via the Center's website, newsletter, policy
briefs, webinars, social media channels, and via our National Advisory Board, whose broad national
membership and reach can accelerate the rapid dissemination of information and create efficiencies of effort in
communicating Center research. This Center integrates transdisciplinary implementation and MH services
research expertise within a healthcare quality framework involving six research institutions, seven academic
disciplines, two state systems, a national dissemination network, and leverages existing NIMH-funded T32 and
D&I training programs.

Public health relevance
OVERALL: Project Narrative Public Health Impact: The proposed Center builds on a 15-year state-academic partnership, a research infrastructure spanning multiple system levels (state, payors, agencies, providers, youth and families) and a national network of stakeholders. It is focused on developing tools to improve the use of research evidence in state child mental health policymaking affecting low-income children with serious mental health disorders (SMHD) and their families, and developing and testing accelerator strategies to improve the delivery of evidence-based care in public health and mental health systems. Consequently, the proposed Center is uniquely positioned to rapidly improve the quality of mental health services for low-income youth with SMHD and their families.